SCH: Enhancing Automated Prediction of Challenging Behavior in Individuals with Autism Using Biosensor Data and Machine Learning

PROJECT SUMMARY (See instructions):
Autism Spectrum Disorder (ASD) is one of the most common childhood disorders (1 in 44 ). Individuals
with ASD have a higher prevalence of challenging behavior (e.g., aggression, self-injury, emotion
dysregulation) that interferes with adaptive development, ranks among the most common causes for
referral to behavioral healthcare services, and incurs high healthcare costs. Over the past four years, the
team at Northeastern University has made significant research progress developing machine learning
procedures that automate the detection of challenging behavior onsets in individuals with ASD using
wearable biosensor data (cardiovascular, electrodermal, and physical activity). Despite our promising
results, issues still need to be addressed to enable practical daily use in real-world contexts. This includes
the need for extensively labeled data, individual calibration from population models to specific individuals,
and handling the non-stationary nature of challenging behavior and physiological data. This project aims
to advance fundamental machine learning theory and techniques that facilitate rapid model
individualization and continuous online model adaptation with little or no labeled data. To this end, we will
contribute to areas including domain adaptation, transfer learning, lifelong learning, and robust modeling
and inference. Three Specific Aims guide the project: (1) Rapid physiological and behavioral data model
individualization; (2) Continuous lifelong physiological and behavioral data model adaptation; and (3)
Validation of model individualization and adaptation techniques with prospective data collected in a clinical
setting from our partners at the Marcus Autism Center at Emory University who specialize in functional
analysis of challenging behavior in individuals with ASD. Across these Aims, we will explore applications
of semi-supervised learning theory, data importance weighting, Support Vector Machines, neural network
models, Hierarchical Markov-Modulated Point Process Models, and Bayesian evidence fusion. The
modeling and inference techniques we develop will be of general applicability to other health application
contexts involving event prediction (e.g., seizure detection) and human action/decision-making (e.g.,
intensive care unit triage).

Public health relevance
RELEVANCE (See instructions): Individuals with ASD who are severely impacted and engage in challenging behavior are understudied and underserved. Our prior work combined with the data and methods produced in this project will lay the foundation for expanding data collection on precursor behaviors associated with challenging behavior and future development of just-in-time adaptive intervention (JITAI) mobile health systems (mHealth) that enable new opportunities for intervention.